Development of targeted cellular therapy for atherosclerotic vascular disease in minority patients

Atherosclerotic vascular disease is a leading cause of death and disability in the United States and around
the world. Despite the advances in cardiovascular drug development, and percutaneous and surgical invasive
procedures, cardiac and cerebral vascular diseases remain a major health challenge and growing global
concern. Advanced atherosclerotic plaque or atheroma (ATH), in the intimal layer of arteries, cause most
acute myocardial infarctions and ischemic strokes, life-threatening emergencies with enormous human and
economic burden. Minority populations with socioeconomic disadvantages are highly vulnerable to a
disproportionate burden of atherosclerotic vascular disease. The cardiovascular health disparities are
associated with regional variations in exposure to risk factors for ATH, including diabetes, obesity, and
cigarette smoking. Arteries with ATH involve heightened levels of inflammation, thrombogenesis, cellular
death, and extracellular matrix degeneration, which contribute to the vulnerability to disruption. In the current
pharmaceutical armamentarium, few single therapeutics have demonstrated ability to repair of vulnerable
ATH. The unmet pathogenic problem is the dysfunction or loss of vascular cells, resulting in an increased
vulnerability of ATH arterial wall to disruption and thrombosis. Vascular Stem Cells (VSC) give rise to new
vascular cells that replace old, dead, or injured cells, and may thereby repair ATH-damaged arterial wall.
Endogenous VSC are rare, and often become dysfunctional when exposed to proatherogenic risk factors.
Moreover, administration of VSC is less effective, due to mechanical stress and the endothelial barrier that
blocks stem cells from entering ATH lesions. Little information is available concerning the vascular stem cell
quantity and quality in peripheral blood of minority patients as few preclinical or clinical studies of VSC have
been performed in minority patients with advanced vulnerable ATH. This research team has recently
constructed and tested several prototypes of echogenic immunoliposomes (ELIP) directed against surface
markers of VSC and inflammatory ATH for targeted VSC delivery to ATH. Evidence from in vitro and in vivo
pilot experiments shows the success of manufacturing dual functional, echogenic immunoliposomes (DF-
ELIP) that recognize and bridge VSC to ATH. DF-ELIP-harboring VSC can therefore promote repair of the
arterial wall injured by ATH. The project scope and product of the current SBIR phase I proposal is to conduct
a proof-concept study of DF-ELIP targeted VSC (dfVSC) for treating diseased arteries harboring ATH. Several
prototypes of dfVSC from minority donors will be prepared or formulated as a cellular therapeutic agent
selectively targeting the inflammatory, vulnerable, and rupture-prone ATH. In principle, DF-ELIP and dfVSC
will be manufactured in a good laboratory practice facility with the standard operating procedure. Their
biosafety, efficacy, and feasibility of mitigating rupture-prone ATH.

Public health relevance
Atherosclerosis, a chronic inflammatory arterial disease, builds plaques in the inner part of arterial wall, leading to vessel lumen narrowing and blood clotting, consequently to two life-threatening conditions, heart attack and stroke. Minority patients exhibit an increased prevalence of advanced atherosclerotic arterial disease, and they need cellular therapy with blood vessel-specialized stem cells for repair and regeneration of their diseased arterial wall. This project will employ an innovative technology to generate nanoparticle- targeted stem cells to repair the arterial wall with advanced atherosclerosis or atheroma.